THE REPRESENTATION OF SEMANTIC CATEGORIES

An understanding of semantic categories (i.e., how people represent the meanings of categories expressed by natural language) is central to many issues in cognitive psychology, such is language, memory, problem-solving, and decision making. In this research project, we are developing a model of semantic category representation that extends and enhances the "classical" approach to category representation by including abstract feature-based representations, and that also accounts for data previously thought to be inconsistent with such a model. To do so, we examine people's representations of natural language categories, and the implications of these representations. In the last year, the model has been extended to explain inter-category differences in class inclusion judgments, cross-cultural differences in category membership and typicality, and people's representations of semantic relations.